Aortic Dilatation in Endurance Athletes: A Physiologic and Mechanistic Study

PROJECT SUMMARY / ABSTRACT
The candidate recently joined the staff at Massachusetts General Hospital (MGH) in the Cardiovascular
Performance Program (CPP), a unique group whose goals include conducting top-caliber human health and
performance research. A core mission of the CPP is to use endurance athletes as a model through which to
study the impacts of exercise on the cardiovascular system. This proposal applies this framework to evaluate
in detail on the impact of exercise on the aorta.
This proposal emerged from the dual observations that a) myocardial adaptation to exercise training is a
well-established process that is felt to be adaptive rather than pathologic, while plasticity of the aorta has not
been documented, and b) endurance athletes with aortic enlargement are commonly encountered in clinical
practice. The candidate accordingly performed an initial study enrolling ~450 athletes and documenting an
elevated prevalence of aortic dilatation in this population as compared to established population norms. This
research proposal aims to define natural history, underlying physiology, and potential mechanisms underlying
this phenotype of aortic dilation in endurance athletes, with the overarching goal of helping to establish whether
this may represent an exercise-associated adaptation vs a novel form of overuse pathology.
To achieve these goals, the applicant proposes to build off his prior work, leveraging the large cohort of
athletes whom he enrolled into the initial study. Longitudinal follow-up will be performed on athlete subjects
using echocardiography to mirror the index assessment. A subset will undergo detailed comparative
physiologic phenotyping with cardiopulmonary exercise testing, advanced echocardiographic techniques
including non-invasive evaluation of intracardiac and aortic blood flow patterns, vascular function profiling, and
detailed anatomic imaging with computed tomography. Where possible, testing will be performed at rest and in
response to physiologic provocation. Phenotypic profiles will be compared across athletes with and without
aortic dilatation and control subjects with aortic dilatation to assess physiologic differences and potential
mechanisms. Molecular evaluation will focus on plasma microRNA (miRNA), a class of molecules with well-
established exercise responsiveness and known mechanistic associations with aortic disease, and circulating
miRNA profiles will be assessed across these groups before and after exercise.
The candidate’s career development plan includes advanced training in exercise physiology, cardiac
imaging and physiologic phenotyping, translational science, and research methodology, all under the
mentorship of a unique multidisciplinary team. The proposed science science will set the stage for future
studies to assess clinical outcomes in this population and integrate additional translational study of exercise-
associated aortic disease, which will form the basis of the candidate’s future R01 proposals. Over the course of
the K23 award, the candidate’s goal is to develop into an independent clinical and translational investigator.

Public health relevance
NARRATIVE Long term endurance athletes are commonly found to have enlargement of the aorta, the largest artery in the body, potentially a highly dangerous condition, leading to speculation that years of exercise training may be a driver of this arterial enlargement. We plan to study whether exercise training may contribute to aortic enlargement through evaluation of a large group of endurance athletes whom we initially enrolled 5 years ago, and our study will include an assessment for interval aortic growth along with a detailed physiologic survey and analysis of potential molecular mechanisms that may contribute to this condition. In doing so, we aim to understand how and why this condition develops, what risks it may confer, and what lessons it may offer for the role of exercise in the treatment of all patients with aortic disease.